Mechanistic Dissection of Lipase (LIPE) Regulation of Fatty Acid Homeostasis as a Parkinson's Disease and Lewy Body Dementia Therapeutic Strategy

Establishing mechanism-based therapeutics for Parkinson’s disease (PD), Lewy body dementia (LBD) and other
synucleinopathies is a biomedical priority. Neuropathological and genetic discoveries implicate α-synuclein (αS)
in familial and ‘sporadic’ PD. Recent publications identify significant lipid components with misfolded αS in Lewy
bodies and Lewy neurites, transforming how we conceptualize PD pathogenesis, as lipids are central to many
fundamental cellular processes and are highly abundant in the brain. αS has physiologic and pathogenic
interactions with phospholipid membranes and fatty acids (FAs) and alters lipid homeostasis. Here, we propose
in vitro and in vivo approaches to dissect the interplay of αS with lipid membranes. Experiments are focused on
advancing PD-dysregulated LIPE (hormone sensitive lipase) as a candidate therapeutic target for PD/LBD in
vivo and establishing the mechanism of rescue centered on αS:lipid membrane interactions at the synapse. We
posit a dynamic relationship between normal and pathological forms of αS and FAs. Our central hypothesis is
that αS dyshomeostasis results in cellular FA metabolism imbalance, altering αS:membrane interactions and
disease phenotypes. This hypothesis underpins the PI’s central goal in this R01: to return the abnormal disease-
associated cellular lipid/FA content to equilibrium in several compelling cellular and in vivo models of PD and
LBD. This proposal has 2 distinct Aims focused on advancing monounsaturated FA therapeutic strategies,
addressing mechanistic and therapeutic questions. 1. We propose a mechanistic dissection of αS:membrane
interactions at the synapse, investigating disease-associated synaptic vesicle abnormalities, αS aggregation,
and the role of membrane FA composition in disease phenotype rescue. 2. We propose to evaluate LIPE as a
therapeutic target for reversal of motor deficits and αS neuropathology with detailed genetic, biochemical,
and pharmacological analyses in multiple mouse PD/LBD/synucleinopathy models. The PI has already
reported a FA target for PD, SCD inhibition, now in human PD clinical trials. Additionally, the PI has published
data generated in support of this proposal in patient-derived neurons identifying LIPE (a functionally distinct,
innovative target) as a candidate PD/LBD therapeutic target. These 2 distinct but complementary Aims should
advance mechanistic understanding of αS:membrane interactions and progress a candidate therapeutic target
(LIPE) for lipid dysfunction in PD and LBD.

Public health relevance
The protein α-Synuclein (αS) and lipid membranes are key components of Lewy bodies (LBs), the hallmarks of Parkinson's disease (PD), Lewy body dementia (LBD) and other synucleinopathies. αS interacts with lipids and fatty acids and alters homeostasis, but despite the brain being highly lipid-rich, the role of lipid metabolism in PD and LBD remains largely unresolved. The PI will lead a diverse team with expertise in lipidomics, αS biochemistry and PD genetics in vivo and in vitro to validate LIPE (hormone sensitive lipase) as a candidate therapeutic target in vivo and establish the mechanism of rescue focused on αS:lipid membrane interactions at the synapse.